Neurostimulation for lower motor neuron bowel syndrome due to incomplete lower motor neuron injury

Sacral or cauda equinal injury due to spinal trauma results in lower motor neuron injury neurogenic
bowel disorder (LMNI-NBD). Due to decreased sacral parasympathetic propulsive control of the distal
colonic smooth muscle and pudendal somatomotor control of the external anal sphincter, the storage
and release function of the rectum and anus are disrupted. This results in a hypocontractile bowel and
sphincter, which manifests as constipation and fecal incontinence, with increased frequency of
defecation and incontinence, increased use of oral medications and dietary modifications directed
toward bowel care, and increased time for defecation and use of the Valsalva maneuver when
defecation is the goal. The constellation of symptoms, treatments and behavioral modifications with
lack of effective treatments contribute dramatically to reduction in quality of life for patients with LMNI-
NBD.
We have recently demonstrated the ability to impose control of function in a parallel pelvic storage and
release system, the lower urinary tract, under conditions of incomplete LMNI. Our model was that of
unilateral preganglionic pelvic nerve transection, as might result from pelvic surgery or trauma. In this
model of neurogenic underactive bladder with detrusor underactivity, we demonstrated on-demand
voiding function using proximal outlet (urethra) neural stimulation, activating positive feedback signals
for evacuation. As such mechanisms are known to exist within the anorectal control system, we
hypothesize that this approach may also be employed to treat LMNI-NBD by local electrical stimulation
of anal canal reflex pathways in patients with incomplete LMNI.

Public health relevance
Neurogenic bowel dysfunction (NBD) due to lower motor neuron injury (LMNI) incurred during military battle action, accident-induced trauma or pelvic surgery is a debilitating condition, resulting in considerable morbidity and reduction in quality of life due to chronic constipation and fecal incontinence. The current proposal seeks to build on our success using proximal urethral electrical stimulation as an effective method for evoking voiding bladder contractions with normal voiding efficiency in a validated surgical rat model of LMNI-induced underactive bladder by applying the same approach to the analogous condition in the distal gut. We will perform preliminary experiments designed to test whether proximal anal canal electrical stimulation may similarly allow for on-demand defecation in a model of LMNI-NBD, following both acute and sub-chronic LMNI.